Cancer Center Administration

ADMINISTRATION – ABSTRACT
The University of Hawai‘i Cancer Center (UHCC) Administration plays an essential role in creating an
environment that fosters collaboration, fiscal stability, and groundbreaking advancements in cancer research,
education, community outreach, and patient care. Our mission is to significantly reduce the burden of cancer in
Hawai‘i and the Pacific. With a dedicated team, UHCC Administration supports the Cancer Center’s Senior
Leadership in driving the development and implementation of our dynamic strategic vision, planning and
evaluation efforts. Led by the Associate Director for Administration (ADA), our exceptional administrative team
comprises Facilities Management, Fiscal Administration, Grants Administration, Human Resources, Human
Subject Compliance, and Information Technology. Together, we collaborate closely with key UHCC
components, including Community Outreach and Engagement (COE), Cancer Research Training (CRT),
Diversity Equity and Inclusion (DEI), Clinical Trials Office (CTO), Shared Resources, and the Cancer Biology
(CB) and Population Sciences in the Pacific (PSP) Research Programs. By leveraging these collaborations, we
facilitate and propel UHCC’s leading-edge research initiatives. Administration oversees an annual operating
budget of $49.1 million, sourced from a diverse range of funding streams, including state funds, university
support, hospital affiliations, philanthropic contributions, extramural grants, and the Cancer Center Support
Grant itself. This financial stewardship enables us to drive transformative research while ensuring strategic
alignment with University, State, and National priorities. Effective coordination and communication are the
cornerstones of our administration’s success. We maintain regular dialogue among team members and Senior
Leadership, guided by the collective group’s expertise and vision. Additionally, we oversee critical aspects
such as Membership policies, operations of the Shared Resources and core research facilities, work order
prioritization, pricing, chargebacks, member subsidies, auditing, user satisfaction, and quality control. Our
commitment to excellence extends to other crucial CCSG activities, including data reporting to the National
Cancer Institute, coordination of Developmental Funds, and administration of pilot projects. UHCC
Administration serves as the central hub for strategic, administrative, and financial planning, driving UHCC
towards exceptional achievements in cancer research, education, community engagement, diversity, and
patient care. Our dedication to innovation, collaboration, and fiscal stewardship positions us as an institutional
leader, inspiring transformative advancements in the fight against cancer.